Laboratory Center (LC): Microbicide Trials Network

The objective of this application is to request an extension of the Microbicide Trials Network (MTN) Laboratory Center due to delays in completion of studies and analysis related to the COVID-19 pandemic. The MTN is an HIV/AIDS clinical trials network established to identify safe and effective microbicides for preventing sexual transmission of HIV in different populations at risk. To accomplish its mission, the MTN conducts scientifically rigorous, ethically sound and highly efficient clinical studies on the safety, effectiveness, pharmacokinetics and behavioral aspects associated with microbicide use. The MTN is comprised of a Leadership and Operations Center (LOG); a Laboratory Center (LC); and a Statistical and Data Management Center {SDMC). The MTN LC ensures protocols are implemented and followed through to completion with proper laboratory support. To fulfill the overall MTN agenda the MTN LC works in cooperation with the MTN LOG and SDMC to provide oversight and coordination of the MTN protocols for laboratory training, specimen collection/management, specimen testing, and specimen quality control. It consists of three cores: Protocol Support, Virology and Pharmacodynamics, and Pharmacology. In addition to supporting laboratory components and analysis for MTN studies, the LC has also provided support in the form of innovative approaches for product evaluation, specimen collection and testing to ensure product safety during protocol development. The MTN LC has provided critical input to support regulatory filings toward licensure of the dapivirine ring. Although the MTN LC was poised for successful completion of its activities by the end of the grant period, there has been significant interruption of its activities due to the COVID-19 pandemic. We are requesting a one-year extension for UM1Al106707 MTN Laboratory Center for successful completion analysis and support for clinical trials which have been interrupted due to the COVID-19 epidemic. Further, completion of clinical trial activities and sample analysis fulfills obligations for scientific quality and integrity and ensures that obligations to study participants and communities who have participated in these trials will be met.

Public health relevance
The MTN Laboratory Center (LC) requests a one-year extension to complete activities supporting clinical trial activity and sample analysis which has been disrupted by the COVID-19 pandemic. Within the extension period, the LC will oversee sample management, complete testing and reporting of results to ensure successful completion of studies directed toward the prevention of HIV.